A Pilot Study to Correlate 4-[18F]fluoro-1-naphthol PET/CT Imaging with Chronic Graft Versus Host Disease Manifestations

ABSTRACT / PROJECT SUMMARY
Allogeneic hematopoietic cell transplant (alloHCT) is a curative therapy for many life-threatening
hematologic malignancies but its full therapeutic potential is undermined by complications such
as chronic graft-versus-host disease (GVHD). Chronic GVHD is the greatest cause of non-
relapse mortality and develops in 25-50% of long-term survivors of alloHCT. Novel approaches
are needed to diagnose and treat chronic GVHD after alloHCT. 4-[18F]fluoro-1-naphthol ([18F]4FN)
is a novel radiotracer that is specific to high energy reactive oxygen and nitrogen species
produced during the respiratory burst in the active innate immune system. The proposed pilot
study will apply [18F]4FN PET/CT to 16 patients with joint and other manifestations of chronic
GVHD to obtain preliminary estimates of the anatomic and temporal correlations between
[18F]4FN PET/CT signal intensity / location and chronic GVHD manifestations. Although PET, CT,
and MRI have previously been used to image chronic GVHD, our approach differs by the use of
[18F]4FN which reflects the functional activity of the innate immunity as indicated by respiratory
burst intensity in contrast to glucose uptake as in [18F]fluoro-2-deoxyglucose (FDG) PET or
anatomical changes as in CT and MRI. Patients will receive one to three [18F]4FN PET/CT scans
and six to twelve Chronic GVHD Assessments. Data from these endpoints will be used to
calculate preliminary estimates of the utility of [18F]4FN PET/CT as a predictive and prognostic /
pharmacodynamic biomarker. We will test the following hypotheses with our specific aims: 1)
[18F]4FN PET/CT images correlate anatomically with chronic GVHD manifestations and selected
[18F]4FN PET/CT images will precede chronic GVHD manifestation changes. 2) [18F]4FN PET/CT
images will provide pharmacodynamic metrics for treatment of chronic GVHD. Information gained
from this pilot study will form the scientific basis for a subsequent larger phase II imaging trial to
evaluate [18F]4FN PET/CT as a quantitative, predictive, and prognostic / pharmacodynamic
biomarker for chronic GVHD. [18F]4FN PET/CT could be applied to other inflammatory conditions
such as acute GVHD and cytokine release syndrome / immune effector cell associated
neurotoxicity syndrome after CAR T cell infusion, and rheumatologic diseases. This multiple
principal investigator project combines the unique, complementary expertise of Drs. Chen
(alloHCT, chronic GVHD) and Piwnica-Worms (molecular imaging, radiopharmaceuticals). In
2022-2023, MD Anderson Cancer Center performed 416 adult alloHCTs of which 13.5%
developed chronic GVHD within 1 year.

Public health relevance
PROJECT NARRATIVE Chronic graft versus host disease (GVHD) is the most common cause of death in long-term survivors of blood cancers who have been treated with a donor derived hematopoietic stem cell transplant. This project will investigate if a novel radiotracer, 4-[18F]fluoro-1-naphthol, can identify and predict for the development of chronic GVHD and its response to treatment when used in combination with a positron emission tomography / computed tomography (PET/CT) scan. Improved methods to detect chronic GVHD may lead to earlier and more effective treatment, ultimately reducing the mortality after donor derived hematopoietic stem cell transplant.